Epigenetics Biomarker of Post Operative Delirium and Long Term Cognitive Decline among Elderly Dementia Patients

PROJECT SUMMARY/ABSTRACT
Delirium exposes patients to a greater risk of developing Alzheimer’s disease and dementia, and patients with
Alzheimer’s disease and dementia are more likely to develop delirium. Delirium among elderly patients is
dangerous and common, yet it is underdiagnosed and undertreated. Especially common in patients with
Alzheimer’s disease, delirium is a strong predictor of poor outcomes including post-operative cognitive decline
(POCD) and mortality. The key to reducing the burden associated with delirium is early identification of those at
high risk for it, especially prior to surgery, which is known to be a major risk factor for delirium. However, currently,
there are no reliable tools available to predict the risk of post-operative delirium (POD). Also, there is no clear
understanding of the pathophysiological mechanism of delirium. The long-term goal of this project is to
investigate the role of epigenetics to better understand the molecular mechanism of pathogenesis of POD and
to identify potential biomarkers associated with POD and POCD. We will test for a specific type of epigenetic
modification, DNA methylation (DNAm), which is known to be induced by environmental factors. Previous
searches for biomarkers of delirium in humans led to the proposal that inflammation and pro-inflammatory
cytokines play a key role in the pathophysiology of delirium. Yet, how the aging process enhances cytokine
release remains unclear. Aging is known to have a strong effect on gene expression, and such changes in gene
expression are tightly controlled by DNAm. Thus, it is suspected that DNAm changes over the course of aging,
leading to enhanced cytokine release due to altered control of gene expression, and that such DNAm
modification contributes to delirium. This project will be the first to investigate the role of epigenetics associated
with POD in humans, and the objective of the project is to identify potential biomarkers for elevated risk of POD
and subsequent patient outcomes related to delirium such as POCD and dementia. The proposed research will
accomplish its objective by following a large sample of elderly patients going through hip fracture surgery
throughout their hospital stay, comparing differences in genome-wide DNAm between those who develop POD
and those who do not. Lastly, the project will test if DNAm is predictive of patient outcomes including survival
and long-term memory problem after surgery. This research will enhance our understanding of the epigenetic
mechanisms in the pathogenesis of delirium and its interplay with the progression of dementia, and may identify
biomarkers predictive of their risk. The identification of epigenetic markers of delirium would hopefully lead to
improvement in medical and surgical practice.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE STATEMENT: Post Operative Delirium (POD) is notorious for its association with poor outcomes including post-operative cognitive decline (POCD) and high mortality, and exposes elderly patients to a greater risk of developing Alzheimer’s disease, and Alzheimer’s disease patients are more likely to develop POD. The discovery of epigenetics biomarkers whereby those at high risk for POD can be identified would lead to optimized patient care, improved patient outcomes, and more efficient allocation of hospital resources. As such, the proposed research investigating the role of epigenetics in POD and POCD is expected to provide important and new information that can be used to help guide the prevention of POD, POCD, and dementia and is likely to facilitate the development of treatments for elderly patients who experience POD.